Digital Delivery of Evidence-Based Mental Health Content and Mentoring to Adolescents

PROJECT SUMMARY. This Direct-to-Phase II SBIR proposal will study Appa Health, a smartphone and computer-based mental health application for adolescents. Appa combines (1) delivery of concise, evidence-based mental health skills via engaging educational videos informed by Cognitive Behavioral Therapy, and (2) trained, supervised mentors with relatable, non-clinical backgrounds who provide structured guidance to facilitate adolescents’ engagement with digital content.
According to Appa’s theory of change, mentorship supports adolescent well-being both directly (through emotional and practical support) and indirectly (by encouraging use of core skills like cognitive restructuring and behavioral activation).
The study will assess the effectiveness and cost-efficiency of the full Appa experience compared to a digital-only version and a waitlist control. A pilot (N=75) will inform procedures and retention strategies, followed by a randomized clinical trial (N=400) evaluating outcomes on depression, anxiety, well-being, and user engagement.
The project addresses the national mental health workforce shortage by testing a model that integrates non-clinical guidance with expert-designed digital content. Appa's innovation lies in combining accessible mentoring with youth-oriented video delivery formats to increase engagement with evidence-based strategies.
The study will also inform Appa’s commercialization efforts, particularly in education and employer markets seeking scalable, outcome-driven mental health tools. Cost-effectiveness analysis will guide product design and service delivery strategies.

Public health relevance
PROJECT NARRATIVE. This partnership between Appa Health and the University of Washington will conduct a randomized controlled trial on the effectiveness and costs of a near-peer mentoring program coupled with videos on cognitive-behavioral therapy skills (Full Appa) as compared to videos alone (Appa Light) and a wait list control group. The study will include a pilot trial to optimize study procedures followed by a fully-powered effectiveness trial, and will collect experience and outcome data on adolescents over 12 weeks of the program. The results of this study will inform marketing and commercialization of Full Appa and possible development of Appa Light as a new product version.